2/2-Testing the impact of early screening on the long-term outcomes of children with ASD

Autism spectrum disorder (ASD) impacts almost 2% of children born today, yet very little is known regarding how to
positively alter the outcomes of affected children. On the one hand, many, including the American Academy of
Pediatrics, believe that early universal screening at well baby check-ups is an important step towards a positive
outcome because it can lead to early treatment. In contrast, the United States Preventive Services Task Force
(USPSTF) recently failed to endorse early universal ASD screening, noting that the benefits of doing so are poorly
understood. What is needed to inform the debate is to examine the outcomes of a large cohort of children detected
very early via universal screening at well-baby checks, and to compare them to children who did not participate in
an early detection program. Here we propose to do just that: We will examine the school age outcomes (age 6-10
years) of an unprecedented sample size of 242 children with ASD detected very early in San Diego and Phoenix (i.e.,
“west coast cohort”) through our Get SET Early program, which involved screening with the CSBS at well baby check-
ups (mean age 17.7 months, range 12-24 months), and immediate referral for comprehensive evaluation and
treatment if warranted. They will then be compared to a cohort of 242 ASD community children matched on age,
gender, race, ethnicity, and SES who did not participate in our early detection program (Total N = 484). Given the
rarity and uniqueness of our cohort, we plan to characterize outcomes not only on traditional measures of cognition,
social behavior, etc., but also on outcome on school achievement (e.g., fully mainstreamed and/or lost their
diagnosis) and family functioning (do families experience less stress?). Since the national mean age of ASD diagnosis
is around 4 years, we expect that children in the community cohort will have later ages of diagnosis and poorer
outcomes than those identified early via the Get SET Early program. With scientific rigor and reproducibility in mind,
we will proactively test the replication of findings in an independent cohort (N=103) of toddlers screened in Boston,
Philadelphia, and New Haven (i.e., “east coast cohort”) through Project Early and a matched community cohort from
the same region (Total N=120). Our specific aims are: AIM 1a: we will identify clinically meaningful outcome subtypes
of ASD in our west coast cohort using unbiased network clustering approaches. AIM 1b: with this unique longitudinal
cohort, we will examine changes in symptom profile, IQ and adaptive functioning between toddler and school ages.
AIM 1c: we will evaluate program impact by comparing the outcomes children in our early-detected to the
community cohort. AIM 1d: we will examine how well findings are replicated in our East coast sample. AIM 2: using
complimentary regression and machine learning techniques, with our total sample collapsed across both west and
east coast cohorts (N=602), we will test our model that earlier age at identification and treatment leads to improved
outcomes. To examine other factors relating to a good outcome, moderating variables such as SES and level of
treatment participation will also be included in our models. AIM 3: since state context (e.g., policies, guidelines) could
also play a role in outcomes, in we plan to collect key state-level information to place our findings in context.

Public health relevance
ASD impacts almost 2% of children, yet factors that positively alter outcomes are uncertain and sharply-debated by the American Academy of Pediatrics that believes early universal screening at well baby check-ups is an important step towards better outcomes, and the United States Preventative Services Task Force that recently failed to endorse early universal screening for ASD. To objectively resolve this impasse, innovative biostatistical and machine learning methods will be used to compare the long-term clinical, educational and family outcomes of two separate cohorts of children initially detected as ASD between ages 12-24 months via universal screening at well-baby checks to outcomes of children with ASD who did not participate in an early detection program. Success of this large and clinically valid first-of-its-kind work will spark more such studies of this vital question, and through that, future pediatric best-practices guidelines for age of detection and treatment of ASD can be properly based on objective evidence and implemented nation-wide.